JOB STATISFACTION AMONG NURSES IN THE DEPARTMENT OF MEDICAL NURSING

This CLINFO STUDY was conducted by the Department of Nursing research committee at the Johns Hopkins Hospital. This descriptive study employed a convenience sample of all registered nurses in the Department of Medical Nursing. Satisfaction levels were compared in specialty units versus general nursing units. Satisfaction and the subscale control/responsibility was found to be lower on specialty units.